Shedding, retention and spreading of chronic wasting disease prions in the environment

ABSTRACT
Chronic Wasting Disease (CWD) is a prion disease affecting natural and captive cervid populations.
This disease is progressively spreading across the United States and new foci of infectivity are constantly
being reported. Despite decades of research, there are still several unanswered questions concerning CWD.
Compelling evidence suggest that CWD prions enter the environment through carcasses from diseased
animals or by the progressive accumulation of prions shed in excreta. Unfortunately, the role that plants,
parasites, predators, and scavengers play in CWD spreading has been poorly studied. During the past funding
cycle, our group made important technical and conceptual contributions in this field. Data from our group and
others (in collaboration) demonstrate that plants can bind prions into their surfaces as well as transport them
from soils to leaves. This is relevant, considering that prions are shown to progressively accumulate in soils
and strongly suggests plants as potential vectors for CWD transmission. Unfortunately, the previously
mentioned evidence has been collected using proof-of-concept conditions, including the exposure of high titers
of rodent (laboratory generated) adapted prions, and grass plants only. We have generated preliminary data
showing that carrots grown in CWD infected soil carry prions in their roots and leaves as evaluated by
bioassays. In contrast, tomato plants do not share these features. The significance of these findings cannot be
ignored considering the interaction of CWD prions with a human and animal edible vegetable. Considering the
use of carrots roots and leaves in human and animal nutrition, and the still unknown zoonotic potential of CWD,
future research involving edible plants is urgently needed. Another relevant (published) finding from our
laboratory involves the high CWD infectivity titers found in nasal bots, a common cervid parasite that develops
in the nasal cavity (a hotspot of prion infectivity). These parasites are found in large quantities in CWD pre-
clinical and clinical deer, and may importantly contribute to environmental CWD transmission. Our research
also identified CWD prions in naturally exposed flies, ticks, and dermestid beetles. However, the prion
infectivity titers in these parasites have not been evaluated. Finally, animals other than cervids, including
hunters and scavengers, are expected to be exposed to CWD prions. Interestingly, we identified CWD prions
and de novo generated porcine prions in tissues from wild pigs living in areas with variable CWD epidemiology.
We plan to further investigate all these events and their relevance in natural prion transmission using a
complementary set of techniques, including in vitro and in vivo systems. Emphasis will be made in analyzing
the strain properties and zoonotic potentials of the prion agents under investigation. For this purpose, we
gathered a unique group of collaborators able to supply us with the samples and expertise required to execute
this project. Outcomes from this research are expected to deliver new insights on this animal prionopathy and
provide regulatory agencies with useful information to control its continuous spread.

Public health relevance
PROJECT NARRATIVE Despite decades of research, several questions remain unanswered for the Chronic Wasting Disease (CWD) epidemic affecting several deer species in the United States. Continuing with our previous R01 project, we will explore novel factors mediating the spread of CWD prions, including different plant types, invertebrate parasites (e.g., ticks, nasal bots) and scavengers (wild boars). These potential disease vectors will be studied for their ability to transmit disease within and across species, including humans.